Implementation strategies to decentralize breast ultrasound services and facilitate timely breast cancer diagnoses in Rwanda

PROJECT SUMMARY
Breast cancer cases and deaths are rising rapidly in low- and middle-income countries (LMIC), including in
sub-Saharan Africa, where most women with breast cancer are diagnosed with advanced-stage disease.
Largely because of late-stage presentations, breast cancer survival in sub-Saharan Africa is poor. To address
these global breast cancer inequities, the World Health Organization has emphasized the need for expanded
access to breast cancer diagnostics in LMIC, and particularly calls for decentralizing diagnostic testing to
primary- and secondary-level health facilities while maintaining care quality. Diagnostic breast ultrasound (U/S)
is an evidence-based intervention that is essential in evaluation of palpable breast abnormalities, including for
determining which lesions require biopsy. However, diagnostic breast U/S is typically only provided by
radiologists, of whom there is a profound shortage in sub-Saharan Africa; further, radiologists are typically
based at urban referral hospitals. This impedes access for low-income rural patients in particular, limiting
quality, equity, timeliness and efficiency of breast evaluation and contributing to diagnostic inefficiencies and
delays. To address this issue, Rwanda’s chief health implementation agency (Rwanda Biomedical Centre) has
called for decentralized provision of breast U/S at district hospitals through task-shifting to non-radiologist
clinicians. Supportive supervision is regarded as essential for successful task-shifting. However, scalable
strategies for clinical supervision of non-radiologist clinicians to ensure sustained provision of high-quality
decentralized breast ultrasound have not been investigated. Our preliminary work training a small group of
non-radiologist clinicians in Rwanda suggests that virtual support through electronically shared images and
asynchronous feedback is feasible and potentially beneficial after intensive training. However, supervision with
real-time teleultrasound technology could be more effective in facilitating sustained ultrasound provision and
quality in a broader population of district hospital clinicians receiving shortened in-person training.
The objective of this research project is to compare 2 implementation strategies (teleultrasound supervision
and asynchronous virtual feedback) to facilitate decentralized breast ultrasound at Rwandan district hospitals.
In Aim 1 we will conduct a hybrid Type 2 implementation-effectiveness trial to compare the strategies’ impact
on penetration of guideline-concordant diagnostic breast ultrasound (implementation effectiveness). In Aim 2
we will compare the strategies’ impact on trainee-performed breast U/S image quality (clinical effectiveness). In
Aim 3 we will estimate the implementation strategies’ costs and cost-effectiveness in facilitating high-quality
breast U/S, as well as exploring downstream cost offsets associated with decentralized breast U/S. This
project will be embedded in Rwanda’s national Women’s Cancer Early Detection Program at government-
funded health facilities. It will directly inform breast cancer diagnosis pathways in Rwanda and shape the
workforce and credentialing processes for breast U/S. In addition, this project will contribute to global
understanding of feasible, contextually appropriate and effective strategies to increase access to breast cancer
diagnostic services through task-shifting in LMIC– a topic of major global interest in light of rapidly rising breast
cancer incidence and mortality in LMIC. This project aligns with the National Cancer Institute’s special
interest in implementation research related to cancer control in low- and middle-income countries and
its commitment to pursuing equity in global cancer control.

Public health relevance
PROJECT NARRATIVE Facilitating earlier breast cancer diagnoses is critical to reduce preventable breast cancer deaths in sub- Saharan Africa, including through expanded access to breast ultrasound which is essential in evaluation of breast masses but typically provided only by radiologists at urban referral hospitals. Task-shifting to non- radiologist clinicians at rural district hospitals could increase patients’ access to breast ultrasound, but strategies to provide clinical support and supervision to these clinicians and facilitate their sustained provision of high-quality ultrasound services have not been studied. This project will examine the implementation effectiveness, clinical effectiveness, and cost of two implementation strategies to build capacity in diagnostic breast ultrasound among non-radiologist clinicians in Rwandan district hospitals.